STAVUDINE IN COMBINATION WITH LAMIVUDINE IN HIV INFECTED WOMEN AND THEIR INFANTS

The objective of this ACTG (332) study is to assess the pharmacokinetics, safety, and tolerance of Stavudine (d4T) in pregnant women, the fetus, and the neonate. A secondary goal is to examine the effect of d4T/cTC combination therapy on the level of virus in the blood. This is an investigator-initiated, industry sponsored clinical trial.